BIOFEEDBACK ASSISTED COGNITIVE BEHAVIORAL PAIN &STRESS MGMT FOR SLE

The primary aim of the present study is to evaluate the effects of a standardized, psychological-behavioral treatment program on quality of life and disease activity among patients with Systemic Lupus Erythematosus (SLE). Specifically, we will provide a biofeedback-assisted cognitive- behavioral pain and stress management treatment (BF/CBT) to SLE patients, and assess outcome in the following areas: pain severity, physical functioning, psychosocial functioning and health care utilization. A secondary aim is to evaluate the potential effects of the treatment program on physician-rated disease activity.